Targeting a Treg deubiquitinase in antitumor immune therapy

Project Summary/Abstract
Tumor growth and metastasis, despite an intact immune system, were considered prime evidence of the poor
immunogenicity of tumor cells, but attempts at immunotherapy to increase anti-tumor responses were largely
unsuccessful. A major hurdle in tumor immunotherapy is the immunosuppression mediated by Regulatory T
(Treg) cells, which function to modulate the immune system by suppressing the function of effector T (Teff)
cells. However, current approaches in targeting Treg have only transient efficacy and are highly unspecific.
The development of new ways to control Treg functions is essential to improving tumor immunotherapy, and is
a central goal of this project. Treg suppressive function is mediated by the transcription factor Forkhehgead
Box P3 (FoxP3). Our preliminary data show that the Ubiquitin-specific peptidase 22 (USP22) is required for
FoxP3 expression, suggesting a critical role for USP22 in Treg suppressive function and stability. More
importantly, genetic USP22 suppression specifically in T cells largely diminished Treg suppressive functions
without impairing, but even enhanced the immune response of conventional CD4 and CD8 T cell activation,
indicating that USP22 is an ideal target to specifically inhibit Treg functions to enhance the antitumor immunity.
Indeed, challenging of both WT and mice harboring a USP22 genetic deletion in Tregs (USP22Treg-KO) with
EG7 lymphoma and B16 melanoma showed an increased in anti-tumor response in USP22Treg-KO mice.
Based on these preliminary observations, we hypothesis that USP22 is a novel regulator of Treg suppressive
functions through modulating FoxP3 expression and a potential therapeutic target to boost the antitumor
immunity. This hypothesis will be addressed in three aims. Aim 1 will focus on studying the role of USP22 on
maintaining Treg suppressive function. Aim 2 will determine the specific molecular mechanisms by which
USP22 mediates FoxP3 expression. Aim 3 will evaluate the preclinical efficacy of USP22 suppression in
antitumor immunity using both xenograft and spontaneous melanoma models. The studies will provide
fundamental insights to Treg biology and regulation, and a rationale for USP22 targeting in antitumor immune
therapy.

Public health relevance
Project Narrative This study will define USP22 as a novel regulator in Treg homeostasis, which advances our knowledge on Treg biology. Our study also identifies USP22 as a novel and powerful target for antitumor immune therapy.